The Interaction of Diabetes and Estrogen on Skeletal Muscle Bioenergetics

Type 2 Diabetes (T2D) is a major health priority within the VA. More than 24% of Veterans have T2D, twice
the national average. There is an increasing population of female veterans in the VA in the premenopausal age
range. Premenopausal women with T2D have poorer health-related outcomes compared with age-matched
men with T2D. The mechanisms for this sex difference in T2D are unknown. Aerobic power predicts the
incidence of the poor health-related outcomes associated with T2D. T2D negatively impacts aerobic power to a
greater degree in premenopausal women with T2D compared with men with T2D. Aerobic power is partially
dependent on skeletal muscle bioenergetics. This proposal is designed to address a clinically significant
knowledge gap related to women with T2D, to identify potential targets for clinical therapies to improve the
health of women with T2D, and to provide training in several specific methods that will prepare me for a
successful transition to independence.
Aerobic power is partially dependent on skeletal muscle bioenergetics: signaling associated with and measures
of cellular energy balance and mitochondrial biogenesis/function. Estrogen (E2) signaling is reported to be
supportive of skeletal muscle bioenergetics, however, my surprising preclinical data suggest that the
physiological context in which estrogen signaling is studied is important. My pilot data reveal an unexpected
adverse interaction of E2 and diabetes on the regulators of skeletal muscle bioenergetics. My working
hypothesis is that diabetes suppresses E2-mediated support of bioenergetics in skeletal muscle of
reproductive aged female rats. I will address this hypothesis with two specific aims:
Aim 1: To test the impact of the diabetic environment on skeletal muscle E2 signaling and mitochondrial
biogenesis in vitro. This aim will determine impact of diabetes on E2-mediated support of signaling associated
with and measures of cellular energy balance and mitochondrial biogenesis. Through intricate signaling studies
data will be generated to identify the diabetes-associated mechanism(s) that could be targeted to restore
mitochondrial bioenergetics in women with T2D.
Aim 2: To understand whether the disruption of E2 support of skeletal muscle bioenergetics in vivo by diabetes
impairs exercise capacity. This aim will determine the bioenergetic consequences of the diabetes-associated
disruption of E2 support of skeletal muscle through measures of substrate utilization, mitochondrial function,
and aerobic exercise capacity.
This proposal addresses the clinically relevant knowledge gap related to decreased functional status of
premenopausal women with T2D and could identify potential targets for clinical therapies to improve the health
of women with T2D. Through training with my mentors, coursework, and the successful completion of the
project specific aims, I will further develop my knowledge base and skillset in primary cell culture, cellular
signal transduction, and manipulation of E2 and derive new data that will set me on the path to achieve my
overall goal of becoming a successful, independent VA scientist.

Public health relevance
Type 2 Diabetes (T2D) is a major health priority within the VA. More than 24% of Veterans have T2D, twice the national average. There is an increasing population of female veterans in the VA in the premenopausal age range. Premenopausal women with T2D have poorer health-related outcomes compared with age-matched men with T2D such as a 3.5 times increase in cardiovascular disease (CVD) mortality. CVD mortality is predicted by aerobic power, and skeletal muscle bioenergetics is a primary contributor to aerobic power. Estrogen (E2) is generally considered supportive of skeletal muscle bioenergetics, however, mounting evidence suggests that the biological context in which E2 acts, such as T2D, is critical to the specific targets of E2 action. Understanding the mechanisms by which T2D impairs E2 support of skeletal muscle bioenergetics will identify potential molecular targets for clinical therapies to improve the health of premenopausal women with T2D.